MicroRNA Function During Neuronal Reprogramming in Treating Spinal Cord Injury

Project Summary:
One major obstacle in treating spinal cord injury (SCI) is to replenish neurons that are lost during the course of
injury and to restore local neuronal circuitry for functional repair. Stem cell transplantation therapy once showed
great promise. However, its efficacy has not been satisfactory in clinical trials; immunorejection and ethical issues
remain problematic. In vivo reprogramming is emerging as a potentially new breakthrough in regenerative
medicine. This innovative technology literally converts endogenous glial cells into functional neurons for repair
purposes, bypassing the challenging questions that stem cell replacement therapies are facing. Previous
research from the PI’s lab has demonstrated that reactive astrocytes can be successfully converted in situ into
functional neurons in both injured brain and brain of a model for Alzheimer’s disease by overexpression of a
single transcription factor NeuroD1 (Guo et al, 2014; BEST of 2014 Article in Cell Stem Cell). However, molecular
mechanisms of the reprogramming process remain elusive. MicroRNAs (miRNAs) are small non-coding RNAs
that play pivotal roles during neural development and diseases. The function of miRNAs could be extensive
given that one miRNA may regulate many target genes through the unique imperfect base-pairing mechanism
exerting a global impact on the gene expression profile in a cell. In this proposal, the PI will combine his expertise
on SCI and miRNA, and examine miRNA function during NeuroD1-mediated neuronal conversion in a mouse
model of SCI. The central hypothesis of this proposal is that miRNAs play essential roles during the neuronal
reprogramming process, and that forced expression of miRNAs, as well as NeuroD1, can reprogram reactive
astrocytes into neurons for functional repair after SCI. The PI proposes three specific aims: 1) To determine
miRNA function during NeuroD1-mediated neuronal conversion in the injured spinal cord; 2) To determine
conversion of reactive astrocytes into neurons by miRNAs after SCI; 3) To determine functional integration of
miRNA-converted neurons and their effects on animal’s behavior after contusive SCI. Completion of this proposal
will show feasibility of miRNA-mediated glia-to-neuron conversion and lay out foundation for therapeutic
application of this small RNA molecule as a synthetic drug in the future. The PI believes that this proposal will
lead to a novel therapeutic treatment for SCI as well as other neurological disorders.

Public health relevance
Project Narrative: In vivo neuronal reprogramming is emerging as a potentially new breakthrough in regenerative medicine. This proposal will examine microRNA function during NeuroD1-mediated neuronal reprogramming in a mouse model of spinal cord injury (SCI) and determine neuronal reprogramming by microRNAs for treating SCI.